MYCOBACTERIAL-MACROPHAGE INTERACTIONS IN AIDS PATIENTS

Mycobacterial infection and disease both with Mycobacterium avium/Mycobacterium intracellular complex and Mycobacterium tuberculosis have emerged as a leading cause of disease in Acquired Immunodeficiency Syndrome (AIDS). The mononuclear phagocyte system is the host defense system that is most important in the body's handling of mycobacteria. Little is known about the handling of mycobacterial in the human mononuclear phagocyte system in the normal host, and probably nothing in AIDS patients. This study proposes to systemically evaluate the ability of peripheral blood monocytes and alveolar macrophages from normal human hosts and from victims of AIDS to ingest and kill Mycobacterium avium/Mycobacterium intracellular complex organisms in vitro. Peripheral blood monocytes will be obtained via venipuncture and alveolar macrophages via lung lavage during fiberoptic bronchoscopy. AIDS subjects will come from patients currently undergoing treatment at Georgetown University Hospital. Age and sex-matched normal healthy volunteers to be used as controls will come from the student body at Georgetown University. Also, the study proposes to evaluate the role(s) of immunomodulators such as complement, interleukins, prostaglandins, and interferons in enhancing or depressing both ingestion and cidal activity in the phagocytes. It is anticipated that the results from this study will lead to a better understanding of the pathogenesis of mycobacterial disease in AIDS victims, and in time lead to improved methods of treatment and/or prevention of mycobacterial disease in AIDS victims.